TASK ORDER 05. NON-CLINICAL ADME STUDIES. TASK ORDER POP: 07/10/2019-07/09/2020. N01DA-16-8931.PURPOSE: THE SCOPE OF THIS TASK ORDER IS A) DEVELOP AN ABBREVIATED LC-MS/MS ASSAY FOR ALMITRINE IN RAT

Task Order Description: The scope of this task order is a) develop an abbreviated LC-MS/MS assay for almitrine in rat plasma; b) conduct a PK study of almitrine in male and female rats; c) assay the plasma samples for almitrine.